Force Platform Embedded Treadmill with Safety Harness System

PROJECT SUMMARY/ABSTRACT
Acquisition of a force platform embedded treadmill with a safety-harness system will enhance the
education, research, and community needs of the Department of Athletic Training (ATRN) and Exercise
Physiology (EXPH) at Midwestern State University (MSU) and the surrounding region. MSU is a predominately
undergraduate, Hispanic-serving institution with a large population of first-generation students (over 40% of
undergraduates) and Pell recipients (42% of undergraduates). The proposed equipment will enhance the
educational experiences of the ATRN and EXPH department’s diverse student population by enhancing the
analysis of participants’ gait during laboratory courses in the department during each 16-week semester. The
treadmill will also advance faculty research into gait biomechanics and assessment of physiologic variables. As
MSU is located over 100 miles from the nearest research-intensive universities in the Dallas-Fort Worth
Metroplex and Oklahoma City, this treadmill will also be the only one of its kind accessible to MSU faculty and
students as well as patients in the surrounding communities who could utilize it for rehabilitative purposes.
Incorporating this equipment into MSU’s laboratory will improve educational outcomes by promoting
applied experiences to enhance student growth and knowledge. The force platform embedded treadmill will allow
undergraduate students in our department to observe multiple factors when assessing VO2 max and other stress
tests performed on a treadmill in the Introductory Exercise Physiology and Exercise Prescription courses. The
master’s level graduate students will be able to practice a more hands-on approach in their courses, such as
Advanced Biomechanics, and utilize this equipment for their thesis projects.
MSU faculty will perform research with athletes and individuals with health-related issues (e.g.
cardiovascular disease, diabetes, orthopedic injuries/disorders). The broad goals of the faculty research
involving the force platform treadmill with safety-harness system will be to aid in the performance outcomes of
athletes and other populations and understand how these populations can improve performance. MSU prioritizes
the inclusion of undergraduate and master’s level graduate students in faculty projects, so faculty research with
this equipment will also provide research experiences for students that will better prepare them for the biomedical
workforce or advanced degrees. Since many of our graduates go on to attain advanced degrees in physical
therapy, access to this equipment will better prepare them for advanced study and careers in physical therapy.

Public health relevance
PROJECT NARRATIVE Acquisition of a force platform embedded treadmill with a safety-harness system will enhance the education, research, and community service capabilities of the Department of Athletic Training (ATRN) and Exercise Physiology (EXPH) at Midwestern State University (MSU). This equipment will enhance students’ preparation for the biomedical workforce and/or advanced study by enabling hands-on laboratory experiences in undergraduate and graduate-level courses. The treadmill will also promote advances in MSU faculty research involving human performance, gait biomechanics, and assessment of physiologic variables in athletes, the general population, and patients from rehabilitation centers in the local community.